Coordination Section

2. ABSTRACT – COORDINATION SECTION
The Coordination Section will provide multidisciplinary scientific leadership for the BCM/Rice Genome Editing
Testing Center. The Section will leverage the multi-PI group’s experience leading large research programs and
expertise in mouse genetics, model development, and resource management; somatic cell genome editing
technologies; and genome editing testing approaches in mouse to coordinate all administrative and scientific
activities of the Center. The Coordination Section, led by the Center multi-PI group and overseen by the Center
Steering Committee, will harmonize the workflows within and between the Center’s sections. This will be aided
by implementation of Standard Operating Procedures and an internal Center communications strategy in the first
year of funding. Meetings of section working groups, all center staff, and the Center Steering Committee will be
used to review section operations, review and select genome editing testing projects for the Center, and track
project and milestone progress. The Coordination Section will implement outreach strategies to facilitate public
relations, project management tools and communication strategies to facilitate customer service, and metrics to
evaluate the quality of Center services and impact on biomedical research. Finally, the Coordination Section will
organize External Advisory Board (EAB) site visits and will be responsible for implementing corrective measures
identified by the EAB.